End-to-end Impedance Modeling Towards Task-Invariant Control of Powered Prosthetic Legs

PROJECT SUMMARY
Millions of Americans live with lower-limb loss, and powered prosthetic legs can return joint functionality via
effectively designed control paradigms. While individual control approaches have shown effectiveness for
multiple primary activities of daily living (ADLs), such as walking on flat ground, ramps, or stairs, the integration
of these approaches into a single unified controller has remained a research challenge. State-of-the-art
approaches use classification strategies to discretely change between various task-specific controllers, but the
susceptibility of this approach to misclassification errors, its finite ability to span ADLs, and its unnaturally abrupt
nature render this approach undesirable. No lower-limb prosthesis controller currently exists that can enable the
primary ADLs continuously and without classification. As such, the objective of this project is two-fold: to discover
explicit models for the relationship between lower-limb kinematics and desired prosthetic joint impedance
parameters (stiffness, damping, and equilibrium angle), and to use these models to develop a novel end-to-end
impedance control paradigm that can allow individuals with transfemoral amputation to seamlessly, accurately,
and reliably span all primary ADLs. Encouraged by tangential relationships in the literature and the preliminary
data presented in this proposal, I hypothesize that at least one model can be discovered for each impedance
parameter of the prosthetic knee and ankle to implement such a control scheme. Specifically, Aim 1 of this
proposal will focus on the model discovery using a publicly available dataset of human locomotion across a wide
range of ADLs. Then, in Aim 2, the discovered models and related findings will be used to inform the experimental
control of a powered knee-ankle prosthesis under a variety of conditions. Successful completion of these aims
will contribute to enhanced understanding of human limb coordination and biological joint impedance, as well as
the development and validation of a novel prosthetic control paradigm that can greatly enhance the performance
of powered prostheses in clinical and real-world environments. These outcomes have the potential to improve
the mobility, independence, and quality of life of individuals with transfemoral amputation and can lead to
complimentary contributions for transtibial prostheses and lower-limb exoskeletons. Additionally, the proposed
technical and professional training will prepare the PI for a successful career as a tenure-track professor at a
research-intensive university, with focus in the fields of lower-limb prosthetic and exoskeleton advancement.

Public health relevance
PROJECT NARRATIVE Current prosthetic leg control methods are unable to realize seamless, accurate, and reliable performance across all primary activities of daily living (ADLs), which is critical for the clinical relevance of these devices. This research aims to model the relationship between lower-limb kinematics and desired knee and ankle joint impedance and to develop a novel end-to-end impedance control paradigm from these findings. This work can significantly impact the mobility, independence, and quality of life of individuals with lower-limb loss, advancing the deployment of powered prosthetic legs for everyday use.